One Health Education: Connecting Humans, Animals, and the Environment

ABSTRACT
The concept of One Health emphasizes the connection between human health, the health of animals and the
health of the environment – with the goal of improving all health. The One Health approach supports
collaborations between physicians, veterinarians, dentists, nurses, ecologists, and other science, health and
environmentally-related disciplines. The One Health approach is increasingly important as our population
rises, agriculture intensifies, and habitat destruction increases.
The goal of our “One Health” project is to increase adolescents' understanding of One Health concepts and the
importance of One Health collaborations. We will accomplish this by developing and disseminating: (1)
Classroom lessons for high school students that are case-based, incorporate hands-on activities, and align
with the Next Generation Science Standards, and; (2) Activities for middle and high school students that are
suitable for use in a variety of informal (non-school) education settings. During this five-year project we will:
• Collaborate with scientists and life science teachers to develop case-based, hands-on One Health lessons
for high school students.
• Develop and use a reliable and valid pre/post assessment to determine the impact of the One Health
lessons on student learning.
• Implement a dissemination plan in which we will recruit, train and support a national network of “teacher-
presenters” to lead professional development workshops for their peers throughout the US.
• Develop activities that will be used for middle school and high school One Health field trip programs at the
University of Rochester's Life Sciences Learning Center.
• Collaborate with informal educators to create One Health activities to be used in their outreach programs.
This project is significant because it will improve students' understanding of the One Health approach to
promoting the health of people, animals, and the environment. This project will also significantly impact
teachers' awareness of One Health, and how One Health concepts are aligned with NGSS and can be
incorporated into their existing curriculums. This project is innovative because it will develop One Health
lessons and activities for use in a variety of settings, through partnerships with scientists, science teachers,
and informal science educators. This project will also feature an innovative model for disseminating the One
Health lessons to teachers nationwide using peer-to-peer professional development.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The relevance of this project to public health is that the lessons and programs to be created and disseminated through this project will improve students' understanding of the One Health approach to promoting the health of people, animals, and the environment. These One Health educational materials will also help students to master scientific subject matter, develop their scientific reasoning skills, and increase their awareness of science and health care careers. This project will also significantly impact teachers' and informal educators' awareness of One Health. This project will thus help participants become better informed for decisions involving their health.